Childhood Asthma in Urban Settings

The overall objective of this study is to provide the NIAID Childhood Asthma in Urban Settings Clinical
Research Network Center (CAUSE) with a highly developed and experienced Clinical Research Center (CRC)
at the Mount Sinai Health Care System. We propose that the Mount Sinai Health Care System is well-
positioned and prepared to create a NIAID CAUSE-CRC to conduct Network and Center-specific studies
based upon: 1) Our success recruiting and retaining subjects in asthma studies from urban populations; 2)
Investigators actively conducting innovative research to understand mechanisms of atopic diseases; 3)
Established and well-organized clinical research programs with committed staff to conduct research studies; 4)
Facilities and institutional support to ensure the success of this proposal; and 5) A large population of high risk
urban children/adolescents with asthma who receive care and participate in research at the Mount Sinai Health
System. The proposed Mount Sinai CAUSE-CRC includes a team of investigators with strong backgrounds
relevant to asthma, allergy, immunology, epidemiology, transcriptomics, microbiome, and systems biology who
have previously collaborated. MPIs Drs. Busse, Bunyavanich and Wisnivesky have served as PIs on several
NIH and PCORI-sponsored asthma and allergic diseases networks (including ICAC-II, III sub-studies) and
individually funded studies investigating determinants of asthma self-management, disparities in care,
mechanisms of airway inflammation, -omics, and systems biology. The Mount Sinai CRC is supported by Co-
Investigators Drs. Wright and Miller who have extensive experience in pediatric asthma network studies. Our
team includes research coordinators, nurses, laboratory technicians, statisticians, bioinformaticians,
pharmacists, and regulatory members who have worked with the investigators which will allow us to
successfully recruit, conduct protocols, maintain the integrity of study data, and coordinate with the LC and
Contract Research Organizations. Our Center-specific project 1, will investigate the influence of concurrent AD
on asthma control in urban children and will be conducted with Dr. Guttman-Yassky, an expert in atopic
dermatitis at Mount Sinai. Project 2 will investigate the association between L-Arginine/Asymmetric Dimethyl
Arginine and asthma morbidity in obese urban adolescents with asthma. Our individual research projects
provide novel information on the mechanisms and a future treatment approach with a more precise benefit in
children with asthma and AD in an urban setting.

Public health relevance
Children and adolescents with asthma living in urban settings suffer from increased disease severity, morbidity and mortality; the NIAID has provided long-standing support of networks to implement improved approaches to care for this at-risk population. Our objective is to demonstrate that the Mount Sinai Health Care System is well-positioned and prepared to create a NIAID Childhood Asthma in Urban Settings Clinical Research Network Center (CAUSE-CRC). We are proposing two Center-studies, which address how the co-morbidities of atopic dermatitis (Project 1) and obesity (Project 2) worsen asthma control in an urban pediatric population, findings of which will guide interventions to improve their outcomes.